Molecular mechanisms of peptidoglycan endopeptidase regulation

PROJECT SUMMARY
Most bacteria maintain a cell wall, an essential, mesh-like structure mainly comprising the polysaccharide
peptidoglycan (PG). Some of our most powerful antibiotics, the b-lactams (penicillins, carbapenems and
cephalosporins) target enzymes required for cell wall synthesis and derive their efficacy from their ability to not
only inhibit cell wall biogenesis, but also to actively cause its destruction. Cell wall destruction after exposure to
b-lactams is mediated by “autolysins”, a group of enzymes (amidases, lytic transglycosylases and
endopeptidase) with the capacity to cut a variety of chemical bonds within the PG mesh. Under normal growth
conditions, autolysins engage in important cell wall remodeling functions, such as PG mesh expansion during
cell elongation; how these functions are regulated to ensure proper PG maintenance is poorly understood. We
have shown that in the diarrheal pathogen Vibrio cholerae, the endopeptidases (EPs) ShyA and ShyC are
required for cell elongation during normal growth, but are also key factors mediating cell wall breakdown after
exposure to beta lactam antibiotics. How ShyA and ShyC are regulated to ensure proper cell wall maintenance
in the absence of antibiotics is unknown. Here, we propose experiments to build a thorough understanding of
mechanisms of endopeptidase regulation in V. cholerae on multiple levels. Since M23 EPs are well-conserved
throughout Bacteria, our experiments will likely yield insights with broad relevance to other pathogens.
Leveraging extensive preliminary screens, we will i) establish how EPs are co-ordinated with PG synthesis, ii)
interrogate the functional interaction between EPs and other autolysins, and iii) determine the role of proteolytic
processing in EP activity regulation. Taken together, these experiments will provide us with an extensive
framework of how bacteria maintain the balance between cell wall synthesis and remodeling, which could
ultimately lead to the discovery of new potential targets for antibiotics that modulate autolysin activity.

Public health relevance
NARRATIVE Due to the alarming rise in antibiotic resistance development, we are in urgent need of new antibacterial therapies. Some of our most powerful current antibiotics (penicillins) are effective against bacteria because they cause unbalanced activity of “autolysins”, self-produced enzymes that kill cells by degrading the cell wall. Experiments proposed here will allow us to understand autolysins better, paving the way for new strategies to exploit bacterial self-destruction through the development of novel antibiotics that target autolysins.